Center for Neuroanatomy with Neurotropic Viruses

PROJECT SUMMARY. Transneuronal transport of neurotropic viruses is uniquely able to reveal the cellular
composition of multi-synaptic circuits. As a consequence, this technique is providing fundamental new insights
into the functional architecture of sensory, motor, cognitive and affective networks in the central nervous
system. The Center for Neuroanatomy with Neurotropic Viruses (CNNV) was created in 2004 to provide the
neuroscience community with access to the highly specialized reagents, training and facilities that are
necessary to use neurotropic viruses as transneuronal tracers.
We document in this application that the CNNV has become an essential national and international resource
for an important segment of the neuroscience community. Users of the Center are funded by 15 different
institutes of the NIH, by NSF and by private foundations as well as international research organizations. The
Center has established a strong history of providing: 1) well-characterized reagents, 2) training and guidance
in the use of the method, and 3) specialized biohazard facilities for performing experiments using neurotropic
viruses. The Center also has played a vital role in the development of new and improved transneuronal tracing
tools that permit more targeted dissection of the functional architecture of neural circuits. Furthermore, the
Center has served as a critical technical and intellectual resource for those interested in using this method.
The goal of this competitive renewal is to enable the Center to continue both its resource and research
functions.

Public health relevance
PROJECT NARRATIVE The ability to treat disease and injury of the brain depends upon developing a fundamental understanding of the complex neural circuits that comprise the central nervous system. The use of neurotrophic viruses as transneuronal tracers provides a unique and powerful tool that reveals the functional organization of these complex circuits. The CNNV is a national resource that provides training in the use of this approach and distributes reagents to a world-wide cadre of investigators.